Closed-loop Control of Interneuron Spike Timing in Epilepsy

Project Summary/Abstract – FROM PARENT GRANT
Temporal lobe epilepsy (TLE) is a debilitating disorder that includes chronic seizures and pervasive memory
impairments that significantly impact quality of life. In rodent models of TLE, my lab and others have found
dramatic changes in brain synchronization with specific changes in the theta phase locking of individual
interneurons of the dentate gyrus. However, it remains unclear whether this abnormal phase locking is a
causal mediator of seizures and cognitive deficits in epilepsy. In order to test whether the timing of interneuron
activity is directly controlling epileptic phenotypes, we have developed a novel closed-loop optogenetic system
to control the timing of interneuron activity during behavior. In this proposal, we will use our closed-loop
optogenetic system to shift the phase locking of parvalbumin- or somatostatin-expressing interneurons and
determine how the timing of these interneurons alters seizure susceptibility and cognitive performance. In
control mice, we will force an abnormal firing pattern onto the interneurons and determine whether this can
drive increased seizure susceptibility and impair cognition. In epileptic mice, we will use optogenetics to
normalize the timing of interneuron activity and determine whether this can reduce seizure susceptibility and
rescue memory impairments. Together, these experiments will determine how the timing of interneuron activity
mediates seizures and cognitive deficits in epilepsy.

Public health relevance
Project Narrative – FROM PARENT GRANT Temporal lobe epilepsy (TLE) is a debilitating disorder that includes chronic seizures and severe cognitive deficits that greatly impair quality of life. There is substantial evidence that the synchronization of brain activity is disrupted in epilepsy but it remains unclear how these changes directly impact seizures and cognitive deficits. This proposal uses a novel system to control the timing of interneurons in epileptic and control mice and will determine how the timing of interneuron firing mediates seizures and cognitive deficits in epilepsy.